The Society of Heart and Vascular Metabolism (SHVM) 21st annual session: Interorgan Crosstalk in Heart and Vascular Metabolism

The goal of the Society for Heart and Vascular Metabolism (SHVM) conference is to bring together scientists
and trainees from around the globe to present and discuss cutting-edge research in the field of cardiac and
vascular metabolism. This year’s meeting in St. Louis, Missouri, September 2024, will focus on the latest
research regarding the role of interorgan crosstalk in the pathogenesis of cardiovascular disease (CVD). Most
prevalent cardiovascular pathologies, such as heart failure and ischemia, have underlying metabolic
derangements directly involved in disease progression, but recent studies have highlighted the relevance of
interorgan crosstalk as a new frontier for cardiovascular research with the ultimate goal of ameliorating CVD. To
that end, SHVM’s 2024 meeting is designed to foster ‘crosstalk’ between the investigative fields of heart and
vascular metabolism and other key organ systems.
Despite new investigations of interorgan communications, such as exosome trafficking as well as novel
hormonal axes that affect the heart and vasculature, cross-disciplinary research has unique funding and
operational barriers. This is not surprising given the significant challenges of creating multidisciplinary
infrastructure and developing novel techniques evaluating heart and vascular metabolism in the context of
manifold interorgan signals. Some scientists/trainees (PhD students, MD and postdoctoral fellows) may not feel
equipped to tackle the unique barriers to performing cross-disciplinary research. To address these issues, this
conference aims to provide a comprehensive and wide-ranging forum in which investigators from multiple
disciplines will interact and discuss recent research studies that have resulted in meaningful outcomes relevant
to cardiovascular metabolism.
SHVM meetings have always featured strong participation of diverse trainees from many different regions
in the United States and from around the globe. Moreover, SHVM has an established track record for fostering
productive collaborations and career advancement. This year’s meeting will offer trainee workshops directed by
top experts in metabolic imaging. Titled, “Cutting edge tools for the evaluation of myocardial metabolic
metabolism and function,” the trainee workshop will facilitate interaction between trainees with junior and
established investigators. The 2024 meeting will feature 2 keynote speakers, 19 plenary speakers, 4 speakers
for Continuing Medical Education talks, 4 Early Investigator winner talks, and 9 other short talks selected from
submitted abstracts, in addition to 2 workshops, and 2 poster sessions. The sessions will have strong
representation from early-stage investigators, women, and underrepresented minorities. We are requesting
funds to offset costs associated with trainee, speaker, and keynote speaker participation to continue the tradition
of SHVM meetings, which are considered the premiere conferences in cardiac metabolism.

Public health relevance
Project Narrative The Society for Heart and Vascular Metabolism (SHVM) will host its 21st annual meeting September 8- 11 in St. Louis, Missouri. Titled, “Interorgan crosstalk in heart and vascular metabolism,” this meeting addresses several critical needs: 1) disseminating new research exploring the effects of ‘crosstalk’ between the heart and other organs; 2) teaching and supporting the next generation of medical researchers; and 3) promoting interaction and future collaboration among researchers of heart and vascular disease.